Accumulation of micro- and nanoplastic particles in mammalian tissues: a translational study

ABSTRACT
The utilization and subsequent disposal of plastics and plastic based products continues to rise exponentially.
Current pervasiveness of micro- and nanoplastic particles (MNPs) in the environment results in significant
exposure to human populations via inhalation and ingestion. MNP contaminants have been discovered in the
air we breathe, the food we eat, and in 81% of tap water samples tested around the globe. Samples taken from
human subjects, including our preliminary data, identify MNP deposition in tissues (e.g., lung, heart, blood,
thrombi, and placenta) and excreta (e.g., semen, breast milk, bronchoalveolar lavage fluid, and feces). These
findings indicate that not only are humans exposed to MNP, but these pervasive part icles bypass protective
anatomical barriers, accumulating within systemic tissues. Animal models reproduce these findings in a
laboratory environment, resulting in MNP accumulation in systemic tissues and associations with pathologic
changes. MNPs have also been identified in the placenta and fetal organs of rodent models after pulmonary or
gastric exposure. Our preliminary data suggest maternal transfer of MNP to the offspring, with MNP deposition
remaining in offspring tissues for at least 2 weeks after birth, 16 days after the last maternal exposure. Despite
the extent of world-wide MNP exposure, the quantified concentration of MNP within systemic tissues is
unknown. Analyses have been conducted using microscopic fixed tissue analyses or chemical extraction-
based techniques. Unfortunately, these methodologies cannot currently be adequately compared. Currently,
there is no “gold standard” methodology that meets all requirements for identifying MNPs in biological tissues.
Furthermore, the role of sex, age, and ethnicity in the accumulation of MNPs in human tissues has not yet
been explored. This project will investigate inter-tissue MNP accumulation in rodent models of MNP exposure
via intratracheal installation or gavage, using overlapping state-of-the-art detection methodologies to quantify
and confirm MNP deposition. We will then compare these concentrations to those obtained from human
autopsy samples. Innovative statistical methods for integrating calibration samples with results from different
analytical methods will be employed to correct for measure errors. These translational studies will provide
further rationale to relate human and laboratory MNP translocation and deposition studies. To fully assess MNP
toxicities, we must first understand the measured mass deposition based on known exposure doses.
Successful completion of these studies will provide the foundational physiological doses to advise fut ure in
vitro and ex vivo MNP toxicological studies.

Public health relevance
NARRATIVE Despite recent extensive reporting on accumulation of microplastic and nanoplastic (MNP) particles in mammalian tissues and excreta, knowledge gaps remain regarding the quantified concentration of systemic organ translocation and maternal transmission to offspring. Using overlapping state-of-the-art methodologies and innovative statistical analysis, this project will investigate MNP accumulation in multiple organs harvested from Sprague-Dawley rats after dosed exposure and from human tissues and excreta harvested at autopsy. This is a translational project, wherein multiple organs harvested from Sprague-Dawley rats after intentional dosing with MNP and from human tissues collected at autopsy will be assessed through mirrored techniques.